Human Heredity and Health in Africa Consortium Biorepository

Principal Investigator:
Institution:
Project Title:
Time Period:
Project Summary
Professor Elizabeth Mayne
Clinical Laboratory Services
Biorepository
August 2022 - July 2023
Specific Aim 1: To provide state-of-the-art sustainable and affordable storage facilities for genomic
DNA and additional samples from H3 Africa research projects and other collaborators in an accredited
facility.
Milestone 1: Optimization of storage services.
We aim to encourage the storage of additional samples by improved marketing strategies and improved
cost-efficiency.
Due to the COVID-19 pandemic national lockdown in South Africa, the site engagement activities have
been severely affected.
The biorepository has engaged the submission sites to obtain a date for deposit of all samples.
See table below for the site engagement status:
Submission siteand PI
Expected
Samples
Samples
Deposited Status
Deciphering Developmental Disorders
in Africa (DDD-Africa) Evaluating
Clinical Exome Sequencing in an
African Setting. WITS S/Africa
Professor Zane Lombard
1500 DNA
samples 250
All samples to be
deposited by the second
quarter of 2023
Hearing Impairment Genetics Studies
in Africa (HI-GENES Africa)
University of Cape Town, South
African
Professor Ambroise Wonkam
1250 DNA
samples 250
All samples to be
deposited by the second
quarter of 2023
Milestone 2: Optimization of nucleic acid quality control protocols (in the context of a comprehensive
biorepository service).
The biorepository conducts policy-mandated DNA and RNA quality control on a defined number of
nucleic acid samples.
1|Page
Specific Aim 2: To provide value-added and innovative biorepository services for sample processing.
Milestone 1: Continue full next-generation sequencing core facility at CLS
Next generation sequencing has been is a core functionality of the sustainability plan. This will be
available as a backup and validation instrument for H3 Africa partners and future collaborators.
Milestone 2: To optimize a protocol for ambient storage of nucleic acid.
Investigate ambient temperature storage as an attractive strategy to reduce cost.
Specific Aim 3: Advocate for biorepository science nationally and internationally
Milestone 1: Establishment of biorepository training and outreach.
A key aim is to build capacity for genomic research and associated disciplines and to provide training for
students who are registered for masters of Science (Medicine) degree, medical professionals including
intern medical scientists in biorepository science.
2|Page

Public health relevance
Wits Health Consortium (Pty) Ltd 31 Princess of Wales Terrace, Parktown, 2193, South Africa Tel: +27-11-274 - 9200, Fax: +27-11-274 - 9360 Postnet Suite 189, Private Bag x2600, Houghton, 2041 Clinical Laboratory Services, a Division of Wits Health Consortium (Pty) Ltd Spencer Lister Building, NHLS Complex, Braamfontein, JHB Tel: +27 10 001 3900, Fax: +27 01 001 3901 Project Narrative Human Heredity and Health in (H3) Africa is a pan-African consortium which investigates genetic predisposition to disease in African cohorts while expanding infrastructure and building capacity through training. Appropriate high-quality biospecimens are central to sustainable research and the H3Africa biorepositories were established to ensure that specimens with associated data were available to researchers. The H3Africa biorepository based at CLS successfully stored all DNA samples from projects in the first round of funding and aims to continue to provide a service to researchers in H3Africa for both storage and sample processing. A wholly owned company of the University of the Witwatersrand _____________________________________________________________________________________ Directors: Prof M.G. Veller (Chairman); Mr. D.C. Arnold; Prof. D.E. Ballott; Dr. R.K. Chikwamba; Mr. P.C. Desai; Mr. A.A. Farrell; Prof. J.N. Mahlangu; Ms. P. Mbikwana; Dr. L.V. Motsepe; Prof. M.A. Papathanasopoulos; Prof. V.H. Rees; Prof. Z. Vilakazi.